Integrative Training Program for Pediatric Sickle Cell Pain

PROJECT SUMMARY
Chronic pain in pediatric sickle cell disease (SCD) is a major clinical challenge due to the complex interaction of
biological, psychological, and social factors. Consequently, current pharmacological and non-pharmacological
treatments have variable and limited effectiveness resulting in the persistence of chronic pain during
adolescence into adulthood. Optimal treatment of chronic SCD pain requires an individualized, interdisciplinary
care approach that targets multifaceted biopsychosocial factors and common psychological comorbidities, such
as pain-related anxiety, fear of movement, and depression, that maintain chronic pain and functional impairment.
The objectives of the proposed research are to partner with patient and family stakeholders to adapt and refine
an existing mind-body, cognitive-behavioral, and neuromuscular movement treatment (Fibromyalgia Integrative
Training for Teens, FIT Teens) to target the unique needs and preferences of families managing chronic pain in
SCD (R61 phase) and conduct a randomized clinical trial to evaluate the effectiveness of the new adapted
intervention (termed I-STRONG for SCD) among youth with chronic SCD pain (R33 phase). The aims of the
proposed study are to: 1) adapt and refine the FIT Teens intervention to develop a new culturally tailored I-
STRONG intervention for youth with chronic SCD pain (R61 phase), 2) optimize the feasibility and acceptability
of I-STRONG for SCD (R61 phase), and 3) conduct a multi-site randomized clinical trial to evaluate initial
effectiveness of I-STRONG for SCD (R33 phase). We will conduct mixed method approaches to collect
qualitative feedback informed by patient and family lived experiences regarding intervention content, format,
perceived benefits, and barriers/facilitators to engagement with youth who have chronic SCD pain and their
parents. Community stakeholder advisory boards and iterative design will inform intervention adaptation and
refinement to enhance clinical implementation. We hypothesize that patients receiving I-STRONG will
demonstrate significant reduction in pain interference and pain intensity (primary outcomes), and significant
improvements in depressive symptoms, pain-related fear of movement, and health-related quality of life
(secondary outcomes), and objectively measured physical activity (exploratory outcomes) at 3-month follow-up
(primary endpoint) and 6-month follow-up. Our long-term goal is to optimize chronic SCD pain management
through a multicomponent integrative approach that will be scalable for broad dissemination.

Public health relevance
PROJECT NARRATIVE Chronic pain significantly diminishes all aspects of quality of life among children and adolescents with sickle cell disease (SCD), yet there are limited effective treatments available to date. This research will adapt and tailor an existing evidence-based innovative mind-body, cognitive-behavioral, and neuromuscular movement intervention to meet the unique needs of adolescents with chronic sickle cell pain and test the new intervention (termed I- STRONG for SCD) in a multi-center randomized clinical trial. The long-term goal of this research is to reduce functional impairment, pain, and common psychological comorbidities such as depression and anxiety, among youth with chronic pain in SCD to mitigate disparities in pain and health outcomes.